Adaptation and assessment of a common element treatment protocol designed to improve mental health

With support from my primary mentor Dr. Borba, my co-mentors Drs. Freier, Dorsey, and Gelaye, and my collaborator Dr. Bird, I propose a comprehensive interdisciplinary research and training plan focused on developing my expertise in clinical intervention research and qualitative assessment of adaptations of mental health treatments for people who have relocated. The proposed study investigates the potential avenues of treatment for mental health disorders that arise due to the stress of relocating. My research program goal is to be an independent researcher and examine mental health treatment for the purpose of understanding treatment seeking and retention for mental disorders for populations who experience stress that leads to mental health disorders, such as people who relocate or move. Preliminary findings from people who relocate under conditions of stress suggest that there are risk factors for mental health particular to the journey context. Thus, this proposal utilizes qualitative methods to examine, and subsequently target, context specific factors that facilitate treatment seeking and retention for relocated populations with mental disorders. Framed within implementation science this proposal will include in person interviews with people who have relocated. These interviews will be leveraged to adapt the Common Elements Treatment Approach, a transdiagnostic intervention, for the unique challenges of relocation. In collaboration with my mentors, I have developed a comprehensive training plan that will prepare me with the requisite skill set for a research career. My training and career development goals are to cultivate skills in: (1) qualitative methods, (2) adaptations of mental health treatments, and (3) analysis of clinical interventions. These skills will allow me to become an independent scientist focused on mental health.

Public health relevance
The relationship between relocation and mental health is complex given the heterogeneous and context specific nature of relocating and, generally speaking, people who have relocated are at increased risk for developing mental health disorders. Yet, despite the relocation being one of the most stressful life events, little is known about the mental health effects and potential treatment targets specifically for relocation. In order to address a significant lack of mental health care seeking and retention in this population, the current multi-disciplinary study proposes a comprehensive examination of factors that serve as facilitators and challenges to mental health treatment seeking and treatment retention in populations who have relocated, which will then be leveraged to adapt and pilot an effective treatment approach to increase retention of people who have relocated in care.